Component: MHC Genetic Core

PROJECT SUMMARY, Core C: MHC Genetic Typing Core
Genetically well-characterized animal models are critical for the success of HIV/SHIV research, including
characterization for MHC genotype, known ancestry, and pedigree relationships. In particular, informative and
accurate MHC genotyping is essential, due to the complexity of the MHC class I loci in macaques, and the
influence of allele type on disease progression. The need for genetically well-characterized animal models for
research must also be balanced against the need to preserve genetic diversity in animal colonies dedicated to
supporting biomedical research. This is a requirement not only to ensure long-term colony health, but to ensure
the relevance of experimental findings to human disease. The ONPRC is a leader in the development in many
of the current recommended approaches and technologies used in genetic typing and management of NHP
colonies. The aims of the Genetics Core for this project are to 1) use state-of-the-art genetic testing to produce
colony offspring of known parentage, ancestry, and MHC genotype and 2) to maintain the genetic diversity of
this extended SPF colony while producing sufficient numbers of offspring to meet research needs. We will
continue to use the Fluidigm 96-SNP parentage array to assign parentage. All new colony offspring will be
typed for MHC Class I alleles using a sequence-based expressed allele assay. We will also conduct genetic
management using new protocols developed to assign genetic value for each animal, and to propose breeding
groups that will minimize the loss of genetic diversity in the colony. Lastly, we will develop new informatics
protocols to support these efforts, including the consideration of MHC type in the maintenance of genetic
diversity.